Summer Training Course in Experimental Aging

Project Summary
This Summer Training Course (STC) will be held for five days each June from 2025 through 2029. The STC
will be directed by Drs. Kapahi and Hansen at the Buck Institute for Aging Research. The course site will rotate
among three host institutions: Buck Institute for Research on Aging at Novato, CA, OMRF/OUHSC at
Oklahoma City, OK, and the University of Washington at Seattle, WA. Similar STCs have been held with great
success every summer since 1993. The STC is designed to foster career development in the field of aging
research, provide trainees with intensive exposure to the latest research in experimental geroscience and
individualized guidance regarding the development of a research proposal. Each year’s enrollment will be
designed for 20 Trainees with most of the Trainees in the formative stage of their careers, i.e., junior faculty in
their first four years or postdoctoral fellows in the last years of their training. Each trainee is expected to have
at least two years of productive laboratory experience in some aspect of biology beyond the doctoral degree
(MD, PhD, or DVM). The five-day program will include the following four activities: (a) overview
lectures/seminars designed to introduce trainees to major areas of geroscience, (b) an opportunity for each
trainee to present their Specific Aims for a research project that will be critiqued by the Training Faculty and a
peer Trainee, (c) seminars focusing on the NIH system and funding opportunities at the NIA presented by NIA
staff, and (d) Panel discussions and workshops, along with after-dinner discussions, focused on the skill sets
needed and challenges of establishing an independent career with an emphasis on grant writing. Nine
scientists will serve as the Steering Committee of the STC and will be responsible for selecting the Trainees
and making changes in the organization or content of the STC: Drs. Kapahi (Director/PI), Hansen (Co-
Director), & Lithgow who will host the STC at Novato (CA); Drs. Miller, Van Remmen, and Richardson, who
will host the STC at Oklahoma City (OK); and Drs. Marcinek, Young, & Kennedy who will host the STC at
Seattle (WA). In each STC, 13 Training Faculty who are leaders in the field of aging and have served on Study
Sections related to aging will participate in each STC. Specifically, in addition to the three STC co-Leaders,
four-six Teaching Faculty will attend from the host institution along with five-seven Visiting Faculty from other
institutions. Following completion, Trainees are asked to review each STC and these reviews are considered
by the Steering Committee when planning the next STC. Trainees will also be offered a 6-month virtual check-
in meeting for further evaluation and feedback. The overall rating of the STCs over the past five years by the
Trainees has been outstanding. 97% of the former trainees who responded to our poll are still involved in aging
research, 85% of the Trainees have been successful in obtaining funding for their research on aging, and 42 of
the Trainees have become new Assistant Professors.

Public health relevance
Project Narrative Aging is a major challenge in biomedicine and the largest single risk factor for several diseases, including cancer, cardiovascular disease, osteoporosis, type II diabetes, and neurodegeneration. With the aging U.S. population, there is a critical need to train researchers to address problems relevant to the biology of aging and age-related diseases. The Summer Training Course in Experimental Aging Research aims to meet this need by providing 20 early-career researchers or senior researchers transitioning to aging research with intensive exposure to key questions in the field, along with personalized critiques and advice on their research plans each year.